Siderophore-like molecules from the opportunistic fungal pathogen Candida albicans

PROJECT SUMMARY Microbial pathogens are faced with unique challenges when acquiring metal micronutrients within a host. As part of innate immune defenses, hosts attempt to starve pathogens of metals in a process called nutritional immunity. One mechanism microbes use to overcome this barrier is to secrete small, metal binding compounds called metallophores (<1.5 kDa) that help scavenge these essential micronutrients. The majority of metallophores described to date are specific for Fe and are called siderophores. Bacteria make a wide assortment of metallophores through various biosynthetic pathways, but only a single biosynthetic pathway for siderophores has been described for fungi. Interestingly, some fungal pathogens like Candida albicans lack this biosynthetic pathway for fungal siderophores, but nevertheless have siderophore receptors. To date no metallophore has been identified for C. albicans. C. albicans is an important opportunistic fungal pathogen and requires metals to survive in the host. My preliminary data suggests that C. albicans does secrete metallophore-like compounds (MLCs) based on their low molecular weight (<1 kDa) and metal binding properties (can bind both Fe and Cu). One of these MLCs, (MLC1) is induced by Fe starvation indicative of a role in Fe homeostasis. We hypothesize that C. albicans produces its own metallophores under metal- starvation conditions and that these are distinct from those produced by other fungi. To investigate this hypothesis, I will pursue the following aims. Aim1. Chemical identification of putative metallophores in C. albicans. To determine the chemical structure of the MLCs, I will first purify the MLCs to homogeneity using HPLC. I will then use high resolution MS/MS and NMR to determine the functional groups, chemical structure and metal-binding specificities of the MLCs. Aim 2. Characterize the function and synthesis of C. albicans metallophore-like compounds. After identifying the chemical structure of these small metal-binding compounds, I will determine the physiological conditions that regulate their production including both metal starvation and metal excess. I will also test whether MLC1 can act as a source of Fe for C. albicans, and whether the known siderophore receptor is required for this process. Finally, I will try to determine the genes involved in the production of these MLCs using the structural information from Aim 1 in combination with transcriptional data obtained from an RNA seq experiment looking for genes expressed under Fe starvation conditions. Together these experiments propose to identify and characterize the first metallophore for C. albicans.

Public health relevance
PROJECT NARRATIVE In this proposal, we will identify small, metal binding molecules made by the human fungal pathogen Candida albicans and characterize their function in providing the pathogen with essential metal nutrients required for pathogenesis.